Training in Molecular and Systems Toxicology

The University of Colorado Anschutz Medical Campus T32 training program in Molecular and Systems Toxicology (MST) provides a multi-disciplinary research mentorship program centered around training in systems toxicology including genomics/epigenetics, proteomics, and metabolomics as well as molecular approaches to understand underlying mechanisms of toxicity. The T32 training program is housed under the multi-institutional Toxicology and Pharmaceutical Sciences graduate programs which are based within the Department of Pharmaceutical Sciences, Skaggs School of Pharmacy, but which includes faculty from the Schools of Medicine
and Public Health on the Anschutz Medical Campus and also includes faculty from National Jewish Health. The MST training program successfully trained 9 PhD students from 2019-2023. For renewal of the MST T32 training program, we are requesting 3 predoctoral positions/year for 2 years of support (in years 3 & 4 for a total of 15 predoctoral trainees over 5 years). The University of Colorado Anschutz Medical Campus MST training program is be supported by 18 faculty which are focused on systems toxicology research and are listed as mentors on this T32 application. This training program has the primary goal and responsibility of developing predoctoral students into independent and successful environmental health scientists with expertise in systems toxicology. This goal will be achieved by utilizing: 1) internationally recognized, well-funded research mentors in systems toxicology; 2) outstanding institutional support from the UC Anschutz campus; 3) targeted didactic learning approaches; 4) training in responsible conduct in research, grant writing and career development; 5) continued
excellence in recruitment and enhancement of diversity; 6) continued student engagement in research, education and career development through various programs; 7) continual development of systems toxicology related coursework and experiences; 8) evaluation metrics to continually improve the MST training program. Ultimately, we expect our trainees to develop into independent scientists with the knowledge and skills to address challenges in toxicology and environmental health using cutting edge ‘omics’ and ‘big data’ approaches.

Public health relevance
Narrative This renewal application is to support a predoctoral training program at the University of Colorado Anschutz Medical Campus in Molecular and Systems Toxicology. The program requests stipend and tuition support for 3 predoctoral trainees in years 3 & 4 of their training (for a total of 15 predoctoral trainees over 5 years). The mission of this training program is to develop students into independent scientists that have skills and knowledge to utilize cutting edge research approaches in `omics' technology to address problems presented by complex exposures to environmental agents, drugs and therapies.